Nonclassical β-catenin signaling in odontogenesis

Abstract
The primary objective of this application is to elucidate the regulatory mechanisms underlying odontogenesis
mediated by nonclassical β-catenin signaling. Tooth agenesis is the most common congenital dental
abnormality, characterized by the absence of one or more permanent teeth including Anodontia, Oligodontia,
and Hypodontia. Human genetic studies of nonsyndromic tooth agenesis have revealed approximately 16
causative genes of which 6 of them are involved in the Wnt pathway indicating its significance in disease
pathogenesis. Missing teeth are currently treated by dental implants, tooth transplants, or prosthodontic
repairs. However, they are not permanent treatments and also are associated with considerable complications.
For next-generation therapies, new regenerative approaches to interrupt tooth formation/maintenance or
develop an autologous tooth replacement are highly attractive concepts. Therefore, it is critical to advance our
knowledge of odontogenesis and elucidate the mechanisms underlying reciprocal interactions of dental
epithelium and mesenchyme. Canonical Wnt signaling mediated by β-catenin has been well established to
play an essential role in early odontogenesis. Mouse genetic studies have demonstrated the importance of Wnt
signaling in various aspects of dental medicine, e.g. tooth development, dental pulp, enamel, odontogenesis,
and amelogenesis. Expression of a degradation-deficient form of β-catenin causes continuous tooth generation
and development of supernumerary teeth, further suggesting that tooth renewal can be unlocked by increasing
the intrinsic level of odontogenic potential. β-catenin acts as a master regulator of this intrinsic potential to
promote tooth formation. However, β-catenin is a multifaced protein that possesses other functions in addition
to acting as a master regulator for transducing canonical Wnt signaling. Preliminary studies of our new genetic
models argue against current knowledge and implicate the requirement of nonclassical β-catenin in
odontogenesis. First, we will characterize new β-catenin mutant mice to rigorously assess the dual function of
β-catenin in the development of odontogenic ability, and differentiation of odontoblasts and ameloblasts.
Second, we will identify the master regulators acting downstream of β-catenin by a single-cell transcriptomic
approach to decipher the genetic regulatory network associated with the nonclassical signaling cascade. The
objective of this study has great significance in human health and regenerative dental medicine. Elucidating the
mechanism underlying the regulation of odontogenesis promises important insights into next-generation
therapy for dental restoration.

Public health relevance
Narrative This proposal investigates the multifaced function of β-catenin in odontogenesis. Using genetically modified mouse strains, we developed new models to elucidate mechanisms underlying tooth morphogenesis mediated by classical and nonclassical signaling of β-catenin. The results obtained are highly relevant to the health of human development because Wnt signaling is causally linked to tooth agenesis and renewal, and understanding the odontogenic potential can facilitate the efficacy of stem cell-based tissue regeneration.